The roles of NK3RMnPO and KNDy neurons in vasomotor symptoms, sleep, and cognition in E2 depleted mice.

Vasomotor symptoms (VMS), a major source of distress for menopausal women, are often accompanied
by sleep fragmentation and other neurocognitive changes (including stress response, memory, and mood
problems), potentially accelerating cognitive aging and increasing the risk of dementia. While low estradiol (E2)
levels trigger these symptoms and they can be modified by stress, the underlying neural mechanisms by which
this occurs remain unclear. Project C of the Brigham/Harvard Reproductive Outcomes of Stress and Aging
(ROSA) SCORE aims to characterize the roles of KNDy neurons in the arcuate nucleus and NK3R-expressing
neurons in the median preoptic area in regulating VMS, sleep, and cognitive processes in a mouse model of
menopause. We first will characterize the role of NK3R neurons in VMS onset and their interaction with stress,
by evaluating expression of stress hormone (glucocorticoid [GC] and CRH) receptors in these neurons and their
involvement in stress-induced changes in VMS. Next, we will investigate how KNDy and NK3R neurons
contribute to sleep fragmentation and cognitive deficits after E2 depletion, using chemogenetic approaches to
selectively activate or inhibit these neurons and then measuring effects on sleep patterns, cognitive performance,
and memory. Finally, we will analyze the temporal activity patterns of KNDy and NK3R neurons during sleep,
wake, and VMS episodes after E2 withdrawal as well as in response to stress, using in vivo calcium imaging.
This work will elucidate the neural circuits underlying VMS, sleep disruption, and cognitive and memory
performance (including the role of stress), with the potential to identify new therapeutic targets. By integrating
analysis of thermoregulation, sleep, and cognition, we aim to develop a comprehensive understanding of how
loss of estrogen and stress exposure impact multiple interrelated systems in a mouse model of estrogen
depletion and VMS. These objectives build on our work in the first ROSA SCORE funding period, investigating
the role of GC signaling in Kiss1 vs GABA neurons in stress effects on puberty, estrous cyclicity, and VMS.
Project C uses a mouse model of menopause to investigate cognitive outcomes that mirror the human
condition, enabling deeper exploration of potential shared mechanisms underlying these menopause-related
cognitive symptoms and the neuronal networks through which stress is transmitted to influence these health
conditions. Project C complements Project A (population level study) and Project B (clinical trial) by providing
mechanistic insights into menopause-relevant hypothalamic neuronal networks that influence sleep, mood, and
cognition in midlife women and how these networks are modulated by stress. Project C will continue to work with
the ROSA SCORE Sleep and Light Resource Core to measure polysomnographic sleep and temperature
changes reflecting VMS events in mice, as well as with the Career Enhancement Core to support the
advancement of early-career investigators studying the neuroendocrine foundations of menopausal cognitive
symptoms that drive risk for dementia in aging women.

Public health relevance
NARRATIVE Vasomotor symptoms (VMS) associated with low estradiol levels in menopausal women are a major source of distress, often accompanied by sleep disruption and cognitive issues, but the underlying neural mechanisms remain unclear. As part of the Brigham/Harvard SCORE Center for Stress and Neural Regulation of Reproductive Aging Health Outcomes, called the Reproductive Outcomes of Stress and Aging (ROSA) Center, we aim to characterize the roles of KNDy neurons in the arcuate nucleus and NK3R-expressing neurons in the median preoptic area in regulating core and skin temperature (biomarkers of VMS in mice), sleep, and cognition in response to stress hormones and/or restraint stress in a mouse model of estradiol depletion. This work will elucidate neural circuits underlying menopausal symptoms and may identify new therapeutic targets.